Genetic Analysis Of Non-alzheimer Dementias

We have used dense SNP based linkage mapping to identify novel loci associated with familial frontotemporal dementia. This work shows linkage overlapping an extant locus on chromosome 9 which we now is understand is also a risk locus for amyotrophic lateral sclerosis. This positional cloning effort is being lead by Dr. Traynor's group (separate report) and this locus was identified by our laboratory. Our ongoing work on dementia with Lewy bodies and Parkinson's disease with dementia primarily focuses on analysis of loci identified in our genome wide association studies in Alzheimer's disease and Parkinson's disease to see if we can tease out the genetic basis of dementia in these disorders which neuropathologically sit between Alzheimer's and Parkinson's disease. We performed and published a genome wide association study in frontotemporal dementia and a focused association study in dementia with Lewy bodies. This work is currently being expanded with exome sequencing and genome wide association efforts. The initial insights reveal genetic but not allelic overlap between PD and DLB